Biomolecular Research Core

Project Summary/Abstract Biomolecular Research Core
The Biomolecular Research Core (BRC) of the COBRE in Matrix Biology is dedicated to supporting
investigators in mass spectrometry, histology and imaging, characterization of molecular interactions, and
design and development of tissue and cell-based models for the study of the ECM in a timely and reliable
manner. The BRC was the first biomedical research core facility at Boise State University. It represented an
initial step in Boise State’s trajectory to become a research university that makes significant strides in
addressing high impact biomedical research issues. Phases 1 and 2 of COBRE support resulted in the growth
of the BRC. To foster a sustainable research environment, the BRC is built on strong institutional support and
skilled research staff. The BRC has become a critical resource for COBRE investigators and many other
investigators across campus. During phase 3, the BRC will provide expertise for planning of experiments,
interpretation of research results, and preparation of publication quality figures and tables. Trained staff will be
available to provide technical expertise as needed and access to specialized equipment. BRC staff will provide
training to new users and early stage investigators as needed. Due to its importance to research infrastructure,
the university is committed to providing dedicated space, maintenance of essential equipment, and support for
training opportunities for new investigators. Institutional support exists for the Core Director, Associate Core
Director, biostatistician, and research technicians. Such support will enable sustainability of the BRC to support
biomedical research investigators as we focus on growing the user base both internally and externally.
Sustaining the infrastructure within the BRC will meet the needs of investigators and further, will allow
expansion of Boise State’s biomedical research capabilities. The BRC will support biomedical research training
and education programs for graduate students through formal courses, one-on-one training, and through
workshops. A business plan to allow sustainability will be based on a fee-for-service model and adopting best
practices of small businesses that apply to share core facilities. Aims for phase 3 include 1) expanding the user
base to ensure long-term sustainability and 2) maintaining effective management and operations for the core.
The BRC has become a key part of research programs across campus and will continue to provide services to
biomedical research investigators beyond phase 3 of the COBRE program.